Expansion of normative database for wide-band acoustic immittance measures to include children and abnormal ears and analyses of data across studies and underlying assumptions

PROJECT SUMMARY / ABSTRACT This work aims to develop wideband acoustic immittance (WAI) measures as a noninvasive auditory diagnostic tool, where WAI refers to the collection of measurements that include absorbance, power reﬂectance, impedance, and related quantities. Potential use of these measures includes (1) detection of ﬂuid in newborn and young infant ears where tympanometry is less successful, (2) identiﬁcation of the cause of a conductive hearing loss (e.g., ﬂuid, disarticulated ossicle, ﬁxed ossicle), and (3) monitoring changes in middle-ear stiffness that result from intracranial pressure changes. The proposed work ex- tends the world's only online WAI database and corresponding website, which was developed during the ﬁrst cycle of this grant, from WAI measurements on normative adult ears to also include ears with speciﬁc pathologies and ears of babies and children. The proposed work also includes (1) laboratory- based acoustical measurements and CT ear-canal scans to understand why the two FDA-approved WAI measurement systems have systematic differences in their measurements and (2) utilizing the database to perform data analyses across studies to compare WAI measures on both normal ears and ears with speciﬁc pathologies in order to identify WAI features that best differentiate between normal ears and ears with speciﬁc pathologies. A second emphasis of the proposed work is the research-based education of undergraduate students at Smith College, an all-women's liberal arts college. Undergraduate engi- neering students will be actively involved in all areas of the proposed work, with the goal of encouraging them to continuing their education at the graduate level.

Public health relevance
PROJECT NARRATIVE Objective noninvasive medical tests do not exist for many problems that can occur within the auditory system. The development of a family of measurements known as wideband acoustic immittance has great potential for detecting a range of middle-ear problems with a simple sound measurement made in the ear canal. Ultimately this approach will lead to better methods for identiﬁcation of the causes of hearing loss for all ages, including newborn babies. The work proposed here will extend the normative data base for wideband acoustic immittance measures that was implemented in the ﬁrst cycle of this grant to include abnormal ears, children, and babies. The work will also include data analyses across studies that are included in the database.